Role of ROP GTPases in sulfate transceptor SULTR1;2-regulated sulfur nutrient sensing

ABSTRACT
Many living organisms including humans have evolved mechanisms to sense and respond to levels of mineral
nutrients or amino acids. In this application, we propose to use Arabidopsis plant sulfur (S) nutrient sensing
and signaling as an experimental system to dissect transporting receptor-mediated nutrient sensing
mechanisms. Our prior research has led to identification of sulfate transporter SULTR1;2 as a receptor. This
type of dual-function transporting receptor, termed transceptor, has been increasingly found in eukaryotic
organisms and is expected to increase nutrient use efficiency by performing both its sensing and transporting
functions. However, how plants use the transceptor SULTR1;2 to transduce the S signal in the control of gene
expression has remained a central unanswered question and becomes the focus of the present project. Our
recent studies have revealed a conserved shortcut model of transcriptional control that links Rho family small
GTPases to RNA polymerase II (Pol II) C-terminal domain (CTD) Ser phosphorylation across plants, fungi and
humans. The Pol II CTD contains various number of conserved heptad peptide repeats (Y1S2P3T4S5P6S7) in
which each amino acid can be subjected to different posttranslational modifications. Thus, the posttranslational
modification pattern is complex and collectively called the CTD code. Among the CTD code, Ser2 and Ser5
phosphorylation along the gene is very important for initiating transcription and completing the transcription
cycle. In the classical model of transcriptional control, upon activation by Rho or Ras GTPases, the MAP
kinase cascade activates transcription factors that bind to gene-specific cis-elements and helps recruit Pol II to
the core promoter. In contrast, in the shortcut model, Rho GTPase signaling directly targets the Pol II CTD
Ser2 and Ser5 phosphorylation and thus can rapidly bring about large-scale gene expression changes. We
now have preliminary evidence indicating that activity of ROP2 GTPase, which is a member of plant-unique
ROP subfamily of Rho GTPases, and levels of CTD Ser2 and Ser5 phosphorylation are impacted by S status.
In addition, ROP GTPase activity is higher in SULTR1;2 mutants. Therefore, we hypothesize that ROP2 and its
functionally redundant ROP4 act as negative regulators in SULTR1;2-mediated S sensing and signaling. The
proposed work aims to fill the major gaps from SULTR1;2 to Pol II transcription. Specifically, Aim 1 is to test
that ROP2 and ROP4 GTPases act as negative regulators in SULTR1;2-mediated S sensing and signaling
using genetic and biochemical approaches. Aim 2 is to test the hypothesis that ROP2-mediated Pol II shortcut
model is required for S response. In Aim 3, we propose to test that ROP2-controlled SLIM1 transcription factor
activity and ROP2-mediated Pol II CTD code modulation act cooperatively to achieve the most productive
transcription of S-deficiency induced S-response genes. The proposed study will not only lead to novel
mechanistic insights into how plants use nutrient transceptor SULTR1;2 and ROP signaling switch to efficiently
control gene expression but also provide a paradigm for transcriptional regulation in other organisms.

Public health relevance
Project Narrative PUBLIC HEALTH RELEVANCE: Understanding signaling mechanisms for transceptors-mediated macro- and micro-nutrient sensing and uptake will contribute to improvement of human nutrition. In addition, transcriptional control has been the key to many physiological or pathological conditions, and thus the cooperative model of transcriptional control has a potential of providing protein targets for drug development in treating cancers and other diseases.